Clinical Translational Research Center for Neurodevelopmental Disorders

Abstract
This is an application for 2025-2026 bridge funding for the Intellectual and Developmental Disabilities
Research Center (IDDRC) at the University of North Carolina (UNC). The UNC IDDRC is an interdisciplinary
program with the overarching goal of supporting and promoting research relevant to understanding the
pathogenesis and treatment of neurodevelopmental disorders. The UNC IDDRC is a critical component of the
Carolina Institute for Developmental Disabilities (CIDD), which is the focal point for clinical services, research,
and training relevant to intellectual and developmental disabilities (IDDs) on the UNC campus. The UNC
IDDRC currently supports 55 investigators from 13 University departments, and includes 110 externally-funded
research projects. The broad-based research program of this IDDRC is integrated around three themes: (1)
Brain and Behavior Development; (2) Autism and Related Neurodevelopmental Disorders; and, (3) Early
Detection/Intervention (including Clinical Trials), and the cross-cutting themes of Genetics/Genomics and
Environmental Influences on IDDs. The UNC IDDRC is a highly collaborative program highlighted by the
presence of several NIH-funded, interdisciplinary research centers/programs. This application seeks support
for the same activities as the currently funded center: (1) an Administrative Core; (2) three research cores – the
Clinical Translational Core, which includes the Research Participant Registry and Brain-Behavior
Measurement Laboratory; the PreClinical Core, which includes the Preclinical Microscopy Core, Preclinical
MRI Core, and the Preclinical Behavioral Core; the Data Science Core Core; and (3) a signature research
project (a continuation of the project in the currently funded center) to study the pathophysiology of CSF and
the meningeal lymphatic system in idiopathic autism, Fragile X syndrome, and Angelman syndrome by
examining the mechanisms and clinical links to increased EA-CSF in etiologically and phenotypically distinct
IDDs, and their mouse-model counterparts. This project has the potential to elucidate novel directions for
targeted treatment development and to identify novel predictive biomarkers. The three proposed research
cores provide cutting-edge, high-quality and cost effective support for this integrated, multidisciplinary,
translational program of IDD-relevant research. Overall, this Center has had a major impact on IDD research
and scientific training at the University of North Carolina, and renewal would allow us to continue our support of
the truly exceptional program of IDD research conducted at UNC.

Public health relevance
Project Narrative This is an application for 2025-2026 bridge funding for the UNC Intellectual and Developmental Disabilities Research Center to provide continued support for research cores that provide critical resources to 55 established investigators and one signature research project. The combined effort of the cores and investigators will have an important positive impact on research relevant to understanding the pathogenesis and treatment of intellectual and developmental disabilities.